Multi-Omics Core

PROJECT SUMMARY (Multi-omics Core)
Single-cell transcriptomics is a central component of the PRECISION Human Pain Network because these
powerful new tools provide unprecedented opportunities for understanding the cell types, molecules, and cell-
cell interactions that contribute to chronic pain. The Multi-omics Core will be led by Dr. Renthal and centralizes
the single-cell transcriptomic, epigenomic, and next-generation sequencing efforts with an experienced team in
both the development, optimization, and analysis of single-cell and next-generation sequencing efforts. The
centralization of these cutting-edge technologies will ensure that the established protocols can be applied
systematically to all samples from the Center. Specifically, the Core will provide single-cell and single-nucleus
multi-omic services to characterize pain-related tissues in both Projects 1 and 2. They will then provide both
Projects rapid next-generation sequencing services with 1-3 day turnaround times at cost. Finally, the Core will
remain at the cutting-edge of the rapidly evolving field of single-cell genomics and continue to bring innovations
that improve quality and reduce costs back to the Center. The Core will also coordinate with similar Cores across
the U19 PRECISION Human Pain Network to reconcile protocols and best practices.